Administrative Core

SCENT TMC Admin Core Abstract:
The Administrative Core of the Duke Senescent Cell Evaluation in Normal Tissues (SCENT) Mapping Center
will support and coordinate the activities of the three other cores: Biospecimen, Biological Analysis, and Data
Analysis. The SCENT Admin Core will be led by Dr. Patty Lee, Chief of Pulmonary Critical Care division in the
Department of Medicine at Duke School of Medicine. The Admin Core will provide leadership, coordination,
oversight, infrastructure, and support personnel to facilitate administrative management; promote integration,
communication, and collaboration; ensure fiscal and regulatory compliance; and oversee data operations and
scientific rigor. By serving these functions, the Administrative Core allows SCENT investigators to focus on
collecting, storing and distributing the relevant tissues, performing the various multi-omics assays, and building
the relevant data analysis pipelines as required by the SenNet consortium. The Admin Core will support each
other SCENT Core leadership team to ensure they collaborate successfully with all members of the Network to
develop metrics for data generation and metadata standards, participate in cross-site studies, engage in cross-
training, and guide development of data analysis and visualization tools that can be used by the broader
scientific community. The Specific Aims of this SCENT Administrative Core are to: 1. Provide administrative
management and oversight of the entire project; 2. Organize and Lead the Executive and Biostatistics Advisory
Committees; 3. Collaborate closely with the SCENT Data Analysis Core and the SenNet Data Coordination
Center to develop harmonious SOPs and generate data packages suitable for the development of the desired
atlases, and; 4. Evaluate novel technological approaches and coordinate activities with other TMCs.

Public health relevance
Narrative – Administrative Core: Senescent Cell Evaluation in Normal Tissues Senescence is a critical part of aging but remains poorly understood. This Administrative Core that will lead and coordinate the efforts of 3 other Cores to apply technologies in different organs across the age spectrum to identify and understand how human senescence happens, with a goal of designing unbiased, data-based, targeted therapies for a range of aging-related diseases.